Integrative Genomics into Genetic Association Studies of Blood Pressure and Stroke in African Americans

PROJECT SUMMARY
Stroke is the third leading cause of death among African Americans (AAs): they are twice as likely to die from
stroke as European Americans (EAs), and their incidence rate is almost double that of EAs. Recent genome-
wide studies (GWAS) suggest there is a substantial genetic contribution to stroke risk in African ancestry
populations, with heritability estimates of about 35%. However, to date, genetic studies in AAs are greatly lagging
behind those in EAs despite their increased stroke burden. Among the risk factors for stroke, blood pressure is
a major contributor: 4 in 10 AAs suffer from hypertension, 50% more than EAs. These disparities have been
considered to be mediated by environmental and social determinants, yet they remain after adjusting for
demographics, socioeconomic status, clinical characteristics, and modifiable health behaviors. Heritability
analysis suggests African ancestry is associated with hypertension, with heritability estimates from 30–40% for
systolic and diastolic blood pressure. However, genetic susceptibility to hypertension among AAs is less well
studied compared to other ethnic groups. Therefore, there is considerable motivation for identifying the genetic
components of stroke and high blood pressure in AAs.
Discovery of genetic variants that predispose to blood pressure and stroke is a crucial step toward
understanding genetic mechanisms that may lead to novel prevention and treatment strategies. Yet, GWAS have
thus far identified genetic loci that together account for only a small proportion of the heritable risk. Substantial
efforts have been devoted to studying the association of genetic variation with gene expression and other
molecular characteristics through large collaborative initiatives such as Genotype-Tissue Expression (GTEx) and
Encyclopedia of DNA Elements. These initiatives have provided a deeper understanding of functional elements
across the genome, which have been used to inform genetic association and identified many novel loci. However,
most of the data in these studies have focused on European ancestry and little has been done in AAs. Our recent
work in Nature shows that genetic discoveries in one population do not readily transfer to other populations.
The objective of this study is to identify variants predicting various genomic features (gene expression,
methylation and protein) in AA samples that have been recently collected through Trans-Omics for Precision
Medicine, the CommonMind Consortium, and GTEx, and to integrate this functional information into genetic
association analysis of blood pressure and stroke in AAs. Insight into both molecular activity and genetic variation
can inform association analysis and enable novel genome-wide discoveries. In particular, we propose to develop
methods that leverage the data for EAs to improve power for identifying genetic variants that regulate various
types of genomic features in AAs, and for integrating the genomic regulation models into GWAS with the ultimate
goal to identify novel loci for stroke risk and blood pressure in AAs. To facilitate these aims we have assembled
the largest number of AAs for genomic studies and AA stroke cases and blood pressure data for GWAS.

Public health relevance
PROJECT NARRATIVE While stroke is the third leading cause of death among African Americans (AA) and blood-pressure is a major risk factor of stroke, genetic susceptibility to stroke and hypertension of AAs is less well studied than that of other ethnic groups. The objective of this study is to identify variants predicting various types of genomic features in AAs, and to integrate the functional regulation information into AA-specific genetic association analysis of stroke and blood pressure. Discovery of genetic variants that predispose to stroke and blood pressure is a crucial step toward understanding genetic mechanisms that may lead to novel prevention and treatment strategies in this under-studied ethnic group.